Examining craving-choice interaction using computational modeling and intracranial recording

Project Summary / Abstract
Substance use disorders (SUD) are a major public health concern in the United States, with an estimated 40
million Americans struggling with at least one SUD in 2020. Despite the tremendous progress made in addiction
neuroscience, there exists a major disconnect in our understanding of craving and addictive decision-making,
which represent two key interacting features at the heart of all compulsive disorders. Addictive decision-making
can directly lead to suboptimal outcomes for afflicted individuals and are frequently studied using value-based
decision-making paradigms. Craving, in contrast, represents the highly subjective urge to ingest drugs and can
persist even after long periods of abstinence. In laboratory studies, craving is often studied with cue reactivity
paradigms; yet it is still debatable how cue reactivity paradigms relate to real-life cravings or addictive behaviors.
As such, the overarching goal of this proposal is to identify the computational and neurophysiological
mechanisms underlying the interplay between craving and decision-making, by leveraging recent advances in
computational psychiatry and human intracranial neuroscience and using cannabis craving as a test case. In
Aim 1, we will identify a generalizable computational algorithm underlying the craving-choice interplay by
deploying a paradigm that assesses craving and decision-making across two independent samples of cannabis
users (online: n=1,000; in-person: n=100). We will implement a joint modeling approach to account for the
bidirectional relationship between cannabis craving and addictive decision-making. We hypothesize that a)
craving will amplify sensitivity (i.e. learning rate) to cannabis-specific prediction errors (CPEs); b) trial-wise
cannabis value and CPE signals will simultaneously modulate cannabis craving; and c) the bidirectional
relationship between cannabis craving and CPE will be modulated by the severity of cannabis dependence.. In
Aim 2, we will investigate the temporal dynamics of the insula-orbitofrontal cortex (OFC) circuitry underlying the
craving-choice relationship. We will conduct intracranial recording in participants who are implanted with epilepsy
monitoring electrodes (n=15) in these brain regions. We hypothesize that a) high-frequency activity (HFA, 70-
200Hz) in OFC will encode drug-specific PEs and HFA in the insula will encode craving intensity; and b) fast
bidirectional information flow between OFC and insula will represent the mutual influence between value-based
choices and craving. In Aim 3, we will explore the causal influence of OFC/insula activity on craving and decision-
making by carrying out targeted intracranial stimulation of OFC/insula. If successful, findings from this project
could provide a formal, neurocomputational account for the “spiral of addiction” that results from mutually
reinforcing relationship between cannabis craving and addictive choices. Furthermore, this framework can be
applied to a wide range of addictive and compulsive disorders, as craving and maladaptive choices are
commonly observed across substance and behavioral addictions. These results might also provide proof-of-
principle for future neurostimulation treatments for these disorders.

Public health relevance
PROJECT NARRATIVE Substance use disorders impose significant challenges to public health. This study aims to identify the brain mechanisms explaining why people crave cannabis and how craving might lead to maladaptive choices and to test novel stimulation approaches to treat these disorders.